Stanford Islet Research Core

STANFORD ISLET RESEARCH CORE (SIRC): PROJECT SUMMARY/ABSTRACT
The specialized expertise of the SDRC Islet Research Core (SIRC) provides SDRC investigators with the
capacity to perform modern molecular, cellular and functional studies of high-quality islets and pancreata from
rodents and humans. The SDRC’s large group of collaborative investigators study a broad spectrum of islet
biology in physiological or pathological settings, including islet development, functional maturation,
maintenance of mature cell fate, proliferation, genetics, epigenetics, gene regulation, inter-organ signaling,
intra-islet cell signal transduction, islet immunology, and aging. A central aspect of the SIRC is our direct focus
on parallel studies in rodent and human tissues. An essential component supporting the majority of studies
falling under this paradigm is our ability to isolate high-quality, well characterized rodent or human primary
pancreatic islets, and then to perform assays of islet cellular, molecular and physiological phenotypes. This is
coupled with a reliable, robust program to procure high-quality human islets that have increased the number of
SDRC investigators studying human islet biology. The support of transplantation-based studies of human islet
cell function, growth and fate by the SIRC also enhances potential translational studies of human islets for
diabetes. In addition to these services, the SIRC is committed to training investigators in specialized methods
of islet biology, like islet isolation and transplantation, islet culture and specialized assays including insulin or
glucagon ELISA, islet perifusion and static batch insulin secretion assays, and immunohistology. SIRC
personnel work closely with SDRC investigators to build efficient experimental strategies tailored to their aims.
These islet-focused services or activities would be lost without P30 support of this unique Stanford research
core. The SIRC also serves the Stanford community and the SDRC by continuously developing new
experimental capacity to match the dynamic demands of modern islet investigations. This includes assays of
islet function, new approaches to investigate human islet cell genetics, new models of islet transplantation, and
assistance in developing new clinical islet programs at Stanford Health Care, like the Stanford Pancreatic Islet
Replacement and Immune Tolerance (SPIRIT) clinical islet transplantation programs. The SIRC also enhances
the use of other SDRC Research Cores by integrating activities with those cores. Together with the Diabetes
Immune Monitoring Core (DIMC) and the Diabetes Genomics & Analysis Core (DGAC), the SIRC collaborates
on efforts permitting cellular, genetic, molecular, physiological and genome studies of human pancreas- and
immune or blood cells, including immune, stromal and vascular cells. The SIRC will also serve SDRC
members at University of California (UC) Berkeley or at UC Davis, including those supported through the
proposed Regional Pilot & Feasibility Award expansion. Based on growth of the SDRC membership, evolution
of exciting new services, increasing membership demand for human islets, and the increased research
focused on islet biology in the SDRC, we anticipate growth of demand for SIRC services in the coming years.